SEXUAL AND PHYSICAL ABUSE HISTORIES IN WOMEN WITH CHRONIC PELVIC PAIN

This research will define the association between CPP and physical, sexual or emotional abuse or neglect in women who are seen in the UNMH gynecology clinics. This case-controlled study will involve a series of questionaires aimed at quantifying womens' sexual and physical abuse histories and relating those histories to their responses in the following areas: Hypochrondriacal beliefs, loneliness and dissociate experiences. CDMAS ONLY.